Myc Physiology in the Pancreatic Beta Cell

Patients with diabetes would benefit from therapies that increase functional β-cell mass. β-cells naturally adapt to increased metabolic demand and insulin resistance by expanding their functional mass, a process that decreases with aging. We have recently demonstrated a critical role for Myc in adaptive expansion of functional β-cells in young but not old mice. Despite multiple studies describing the effect of Myc overexpression in beta cells, there is a knowledge gap about how this crucial anabolic transcription factor perceives and responds to nutrients and increased insulin demand in its native context. How do nutrients regulate Myc expression in β-cells? How does Myc participate in the regulation of GSIS and mitochondrial function in the β-cell, how does Myc fail to increase adaptive proliferation in aged β-cells or will targeted demethylation of specific Myc binding sites increase β-cell proliferation in metabolically-stressed aged β-cells? These important questions about the physiological role of Myc in the β-cell need to be answered to advance our knowledge and find therapeutic means to treat diabetes. Our overarching hypothesis is that Myc is critical for adaptive β-cell growth and function, and reversing Myc resistance in the T2D-prone or metabolically-stressed aged β-cell can lead to an enhanced adaptive response. We will test our hypothesis by completing the following specific aims: 1) To elucidate how nutrients physiologically upregulate Myc in β-cells and whether Myc upregulation is required for adaptive glucose and β-cell homeostasis in insulin resistance; 2) To determine the physiological role of Myc on insulin secretion and mitochondrial bioenergetics in the β-cell; and, 3) To uncover and modify the mechanisms impairing Myc action in the metabolically-stressed, aged, and T2D β-cells. These studies will deliver unprecedented insight into how Myc is regulated by nutrients, how Myc regulates β-cell function and how to overcome Myc resistance in the metabolically-stressed aged β-cell, which will provide a crucial basic platform for designing and testing novel therapeutic strategies for the treatment of diabetes.

Public health relevance
In this proposal, we will fully define the importance of Myc for adaptive β-cell growth and β-cell function in insulin resistance conditions, and how reversing Myc resistance in the T2D-prone or metabolically-stressed aged β-cell can lead to an enhanced adaptive response. These studies are directly relevant to the many millions of patients with diabetes worldwide whom will benefit from the knowledge generated with these studies that could lead to the development of a therapeutic strategy to treat this disease.